Evaluation of NIAID's HIV Vaccine Research Education Initiative

This contract will DESIGN A PROGRAM EVALUATION PLAN and CONDUCT PROGRAM EVALUATION on awareness of, knowledge about, and support for HIV vaccine research among the target U.S. populations in conjunction with NIAID's HIV Vaccine Research Education Initiative